Microphysiological systems to recapitulate and interrogate Sjögren’s disease salivary gland pathogenesis

PROJECT SUMMARY
Sjögren’s disease (SjD), a systemic autoimmune disease that affects four million people in the United States and
impairs health-related quality of life, has no FDA approved disease modifying treatments available. SjD is highly
heterogeneous and has multiple endotypes or pathobiologically similar subgroups. The standard for studying
complex cell interactions and organ systems in SjD is mouse model work. Unfortunately mice fail to fully
encapsulate all features of SjD and also are homogeneous. Thus, a system is needed that can recapitulate both
the complex interactions in vivo but also the heterogeneity of SjD. Our long-term goal is to leverage
microphysiological systems (MPSs) to test SjD therapeutics. The goal of this project is to capture the functional
effects of a fibrotic microenvironment in SjD progression. The hypothesis of this project is that MPSs
incorporating collagen density and fibroblasts will more faithfully reproduce in vivo epithelial cell and lymphocyte
phenotype and transcriptome, ensuring our MPS is more physiologically relevant for future therapeutic testing.
The rationale for this hypothesis is based on the fact that in mice, fibroblasts are necessary for germinal center
formation in salivary glands and that fibroblasts under inflammatory conditions promote CXCR3+ CD4+ T-cell
chemotaxis. Furthermore, SjD patients have more fibrosis of salivary glands than non-SjD patients, independent
of age. In other diseases, fibrosis and collagen density affect lymphocyte chemotaxis. Yet, the effects of collagen
density and fibroblasts remain unclear in SjD. The central hypothesis will be tested by pursuing two specific
aims. Aim 1 will interrogate collagen density effects on SG-organoids and lymphocyte extravasation and
chemotaxis. MPSs will be generated with various collagen densities. Lymphocyte chemotaxis to salivary gland
organoids will be evaluated with and without the presence of fibroblasts. Aim 2 will compare MPSs to in vivo SjD
models, using pharmacologic probes. We will contrast the effect of JAK inhibitors on lymphocyte chemotaxis as
well as on peripheral blood mononuclear cells, fibroblast, and organoid cell signatures in our MPS as well as in
a relevant mouse model. This project builds an interdisciplinary team with unique expertise in SjD and salivary
gland biology, MPS experts, and experts in seqFISH and hybridization chain reaction. The proposed application
is innovative because it uses cutting edge MPSs and approaches to measure spatial genomics and proteomics
of the MPSs. It also defines the effect of collagen density on the local immune environment. This research is
significant because it will improve novel therapeutics screening and selection, leveraging a complex system
that recapitulates SjD. Furthermore, this MPS is capable of recreating specific SjD endotypes to tailor research
to SjD heterogeneity.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will build foundational pathogenic understanding of Sjögren’s disease (SjD), a common systemic autoimmune disease characterized by oral and ocular dryness and marked morbidity, with no available disease modifying treatments. This proposal leverages cutting edge microphysiological systems, spatial genomic and protein profiling technology to define the effect of fibroblasts, collagen density, and drugs on salivary gland organoids, fibroblasts, and lymphocyte chemotaxis. Thus, the proposed research is relevant to the NIDCR’s mission that pertains to improving oral and dental health through research.